Clinical Central Laboratory Services to support a VTEU trial for an Influenza vaccine

To support clinical laboratory services in support of research studies and trials of infectious disease countermeasures supported by NIAID.